DREAMS - Pilot and Feasibility Program

The DREAMS-CDTR maintains a robust Pilot and Feasibility Program that supports studies that lead to future R-level and K-level grants in diabetes translational research. This Program aims to support two Pilot and Feasibility studies in each year of the CDTR renewal, conduct peer review of Pilot and Feasibility award applications on an annual basis, and leverage the Pilot and Feasibility awards as a mechanism to support junior investigators in developing robust careers in translational research in diabetes and diabetes prevention. To ensure the continued success of the P and F program, The DREAMS-CDTR will work with the External Advisory Committee to evaluate progress with stated goals, as well as gather feedback from P and F awardees regarding specific activities on an ongoing basis.